The Ohio State University Chronic Pancreatitis Diabetes Pancreas Cancer (CPDPC) Clinical Center

ABSTRACT
The mechanistic underpinnings of diseases involving the exocrine pancreas are poorly understood. Chronic
pancreatitis is often accompanied by inflammation of the pancreas, irreversible fibrosis, and destruction of the
pancreatic parenchyma resulting in abdominal pain, malnutrition, exocrine pancreatic insufficiency,
pancreatogenic diabetes, and, in some cases, pancreas cancer. We have developed a network of adult and
pediatric investigators to form The Ohio State University Clinical Center (OSU CC). In a multidisciplinary
collaboration with other clinical centers in the Consortium for the Study of Chronic Pancreatitis, Diabetes, and
Pancreatic Cancer Clinical Centers (CPDPC-CCs) (U01), the OSU CC has helped develop four (4) major
observational studies during the initial funding cycle to address research gaps in our understanding of diseases
of the exocrine pancreas. Specifically, the OSU CC seeks to validate proposed diagnostic biomarkers in
chronic pancreatitis, pancreatogenic diabetes, and pancreas cancer.

Public health relevance
Project Narrative We have developed a network of adult and pediatric medical research institutions to form The Ohio State University Clinical Center (OSU CC). In a multidisciplinary collaboration with other clinical centers in the Consortium for the Study of Chronic Pancreatitis, Diabetes and Pancreatic Cancer Clinical Centers (CSCPDPC- CCs) (U01), the OSU CC has helped developed 4 major observational studies during the initial funding cycle that address research gaps in our understanding of the exocrine pancreas. Specifically, the OSU CC seeks to confirm and validate proposed diagnostic biomarkers in chronic pancreatitis, pancreaticogenic diabetes and pancreas cancer.